Mechanisms of TGFbeta and Smad signaling in tendon regeneration and fibrosis

? DESCRIPTION (provided by applicant): Tendons are dense, load-bearing tissues that transmit muscle forces to the skeleton. Upon traumatic injury or degeneration, load-bearing function is frequently compromised due to poor intrinsic healing that is dominated by fibrotic scar formation. Despite tremendous interest, the biology of tendon healing remains poorly defined and many of the cell and molecular factors that mediate these events have not been identified. One major signaling pathway with high therapeutic potential for tendon is TGFβ, which has been implicated in multiple aspects of tendon cell biology including development, regeneration, and fibrosis. Despite the importance of TGFβ signaling, the mechanisms by which TGFβ may drive these divergent processes remain unknown, which has limited effective therapeutic application. Therefore, the goal of our proposal is to distinguish the tenogenic vs. fibrotic functions of TGFβ signaling in the context of injury using a novel model of neonatal regenerative healing and a model of adult fibrotic healing. Using inducible mouse technology which enables cell-specific targeting and temporal control of gene recombination, we will determine the role of TGFβ (Aim 1) and downstream Smad (Aim 2) signaling in the specific cell populations that drive healing. Aim 3 will use a tissue engineering platform to determine whether limitations in adult tendon healing are due to poor intrinsic tenogenic capacity and identify potential Non-Smad mediators of tenogenesis. Successful completion of this project will uncover the tenogenic vs. fibrotic requirements for TGFβ and Smad signaling, which will ultimately enable the development of targeted cell therapies modulating TGFβ signaling to enhance tendon differentiation while attenuating fibrosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: Tendon ruptures and tendinopathies are painful and debilitating conditions affecting a large portion of the adult population. Due to poor intrinsic healing, tendon injuries often lead to fibrotic scarring, chronic pain and loss of function. From a regenerative standpoint, there is a pressing clinical need to identify the cell and molecular mechanisms regulating tendon differentiation vs. fibrotic scarring in order to improve repair outcomes. Since the TGFβ signaling family has been implicated in both tendon differentiation and fibrosis, the objective of the proposed studies is to test TGFβ family molecules in tendon healing via conditional loss of gene function in the specific cells that drive healing.